Intraoperative Stereovision for Surgical Guidance

PROJECT SUMMARY/ABSTRACT:
InSight Surgical Technologies, LLC, is a start-up founded by senior members of a long-standing NIH-funded
research effort to develop intraoperative image updating that maintains accurate image correspondence with
the surgical field throughout a procedure. The effort has led to research innovations that have generated an
intellectual property (IP) portfolio of 13 issued and 8 pending patents. Phase I demonstrated feasibility of new
algorithms for assembling multiple intraoperative stereovision (iSV) acquisitions into a composite field-of-view
and accomplishing iSV-to-MRI registration/re-registration, and conversion of existing iSV algorithms for 3D
surface reconstruction and calibration in graphics processing unit (GPU) accelerated forms. Additionally,
Phase I results obtained during resection of a large animal (swine) brain tumor indicate this model is a superb
system for testing and validating InSight’s complete image updating system, I2UpdateTM, in vivo in Phase II.
Specifically, we will leverage Phase I results to automate I2UpdateTM fully, and demonstrate its technical
performance and clinical functionality under quality systems sufficient to meet regulatory requirements. Specific
aims will (i) develop a fully-automated, GPU-enabled processing system for intraoperative image-updating
(I2UpdateTM), (ii) complete verification testing and pre-clinical in vivo validation of I2UpdateTM, under quality
system controls sufficient for supporting regulatory filings at the end of Phase II, and (iii) conduct a multi-site
clinical-use study with I2UpdateTM under non-significant risk in patients undergoing brain tumor resection.
Successful completion of Phase II will produce the I2UpdateTM product platform as a finalized commercial
GPU-enabled software system with concomitant design control, software validation, procedural use and quality
systems, accompanied by in vivo animal validation and multi-site, multi-surgeon use demonstrating clinically-
relevant and acceptable image-updating performance in terms of automation, computational efficiency and
registration accuracy.

Public health relevance
PROJECT NARRATIVE In this Phase II proposal, we will leverage impressive Phase I feasibility results to research and develop the I2UpdateTM software product platform as a commercial GPU-grade software system with concomitant design control, software validation, procedural use and quality systems sufficient for FDA regulatory filing in the future, accompanied by in vivo animal validation and multi-site, multi-surgeon use demonstrating clinically-relevant and acceptable image-updating performance in terms of ease-of-use, efficiency and accuracy.